Comprehensive Genomics

COMPREHENSIVE GENOMICS SHARED RESOURCE
PROJECT SUMMARY/ABSTRACT
Comprehensive Genomics is integral to understanding the molecular pathophysiology of cancer and the
discovery of improved diagnostics and treatments. The Comprehensive Genomics shared resource
(Genomics) of Rutgers Cancer Institute of New Jersey (CINJ) is an Institutionally managed shared resource
whose purpose is to provide centralized, high quality, cost-effective cutting edge genomic analyses of cells and
tissues.
This shared resource has been greatly expanded over the last grant period and now resides within the Rutgers
University Cell and DNA Repository (RUCDR-Infinite Biologics) and includes a large suite of next-generation
sequencing technologies. This reorganization allowed CINJ to address the suggestion to develop next-
generation sequencing capabilities by leveraging the significant resources and instrumentation available at
RUCDR to serve the needs of Cancer Center investigators. The two highly trained and experienced CINJ staff
members remain with the shared resource and now work within RUCDR, dedicated to serving the needs of
Cancer Center members. Both staff members report to the Co-Directors, provide local consultation services,
and arrange for seamless sample transfer. RUCDR is home to state-of-the-art biosample-processing
instrumentation, robotic workflows (including a fully automated robotics facility for sample handling from nucleic
acid extraction to sequencing), integrated quality control, and a suite of sequencing platforms. Sequencing
data is transmitted back to investigators either on flash drives or electronically, usually in coordination with the
Biomedical Informatics shared resource.